Equipment Supplement for 5R35GM119462: Deciphering dynamic signals in control of cell fate decisions

Project Summary not required, refer to:
NOT-GM-22-017: Notice of Special Interest (NOSI): Administrative Supplements for Equipment
Purchases for Select NIGMS-Funded Awards (nih.gov)

Public health relevance
Project Narrative not required, refer to: NOT-GM-22-017: Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for Select NIGMS-Funded Awards (nih.gov)